Transplantation of human stem cell-derived neurons for retinal ganglion cell replacement and optic nerve regeneration.

Project Summary / Abstract
Optic neuropathy causes irreversible vision loss because humans and other mammals cannot repair the optic
nerve or repopulate the nerve cells that comprise it (retinal ganglion cells or RGCs). Glaucoma, the most
common optic neuropathy, is projected to affect more than 110 million people by 2040, and to cause bilateral
blindness in more than 10% of them. Stem cell therapy holds great potential for treating neurodegenerative
diseases that currently have no cure, including glaucoma and other optic neuropathies. By generating human
RGCs in a dish and transplanting them into the eye, it might be possible to replace lost RGCs, regenerate the
optic nerve, and reverse blindness from optic neuropathy. Achieving RGC replacement will require significant
advances in our ability to ensure survival of transplanted cells and facilitate their communication (integration)
with the visual system. Significant work is ongoing to develop methods to drive RGC nerve fiber (axon) growth
towards visual centers in the brain. However, RGC survival after transplantation and communication with other
neurons in the retina (i.e. bipolar and amacrine cells) are equally important and have been less well studied.
Through this mentored clinician-scientist career development project, Dr. Thomas Johnson proposes
to advance the field of stem cell transplantation for optic nerve regeneration by improving survival and
retinal integration of transplanted human RGCs. To so, he will address three specific aims: (1) Generation
of novel human cell lines genetically engineered for improved survival after transplantation by targeting
molecular pathways involved in RGC death and neuroprotection; (2) Determination of how optic nerve
neurodegenerative disease states affect survival and integration of RGCs transplanted into the eye; and (3)
Elucidation of how transplanted RGCs sense barriers to retinal integration and development of methods for
overcoming these obstacles. The proposed work will address key limitations of prior translational optic nerve
regeneration research by using experimental models that are more applicable to human disease, increasing
the experimental rigor of transplant outcome assessments, determining which RGC subtypes are most likely to
survive and integrate, and controlling for “material transfer” from transplanted cells to the recipient retina.
Dr. Johnson is an early-career glaucoma specialist and neuroscientist who will conduct this project in an
outstanding research environment at Johns Hopkins’ Wilmer Eye Institute, under the mentorship of an
interdisciplinary team of senior investigators, including Drs. Don Zack, Harry Quigley, and Alex Kolodkin. Over
five years he will acquire expertise in emerging molecular biology and neuroscience techniques required for
achieving his long-term goals of: leading an independent high-impact optic nerve regeneration research
laboratory, providing outstanding medical and surgical care to patients with glaucoma; and bridging the gap
between the clinic and laboratory by helping to usher in a new era of glaucoma treatment though RGC
replacement and optic nerve regeneration.

Public health relevance
Project Narrative Glaucoma is a chronic optic nerve disease and the most common cause of irreversible blindness in the world. Though stem cell transplantation holds promise as a future treatment capable of restoring vision through optic nerve regeneration, translating this therapy to patients requires improved understanding of the factors that limit survival and integration of neurons into the visual system after intraocular transplantation. This mentored clinician-scientist training plan proposes to study in rigorous detail how human RGCs generated from stem cells survive and functionally integrate with the retina in multiple models of optic nerve degeneration, and tests methods for improving these outcomes on the path towards functional RGC replacement.